Epithelial cell mediated fibroblast activation through CTHRC1-TGFb signaling in fibrotic lung diseases

ABSTRACT
Fibrotic lung diseases represent a heterogeneous group of diseases resulting from a variety of
genetic defects, immune conditions, or inhalational exposures. Fibrosis can manifest in the lung
airways in the form of bronchiolitis obliterans (BO) or in the lung parenchyma as in idiopathic
pulmonary fibrosis (IPF). Effective pharmacological treatments are lacking for lung fibrosis. As a
result, fibrotic lung diseases such as BO and IPF are associated with high morbidity and mortality,
and understanding mechanisms of lung fibrosis represents a critical area of need. In this proposal
we seek to answer a fundamental question in lung fibrosis – what are the mechanisms that lead
to fibroblast activation from normal pulmonary fibroblasts to abnormal fibroblast populations.
Supported by novel preliminary data, we identified CTHRC1, a secreted glycoprotein, as
important not only as a marker of fibroblast activation, but as a key regulator of fibroblast activation
upstream of TGFβ signaling, an important pathway implicated in fibrosis phenotypes. In Aim 1,
we will evaluate important airway epithelial cell-fibroblast interactions contributing to CTHRC1-
mediated fibroblast activation in the context of bronchiolitis obliterans, a fibrotic airway disease.
In Aim 2, we will evaluate alveolar epithelial cell-fibroblast interactions contributing to CTHRC1-
mediated fibroblast activation in the context of idiopathic pulmonary fibrosis, a fibrotic lung
parenchymal disease. We will leverage Duke University’s status as one of the largest lung
transplant centers to directly investigate these questions in human explanted lungs using single
cell and spatial transcriptomic analysis as well as sophisticated primary human cell culture
techniques. These studies will demonstrate a common mechanism of fibroblast activation in
different lung fibrotic diseases and identify a novel therapeutic target in CTHRC1 and its
downstream effectors for treatment of fibrotic lung disease. The data gathered during this award
period coupled with ongoing mentorship and a multi-disciplinary research environment will
prepare me to fulfill my long-term goal of becoming an independent physician-scientist.

Public health relevance
PROJECT NARRATIVE Fibrotic lung diseases represent a heterogeneous group of diseases that arise from a variety of genetic defects, immune conditions, or inhalational exposures. The molecular mechanisms contributing to fibrosis remain unclear, and new therapeutic approaches remain a critical unmet clinical need. Supported by novel preliminary data from human explanted lungs, we propose to investigate CTHRC1 and its downstream targets as a promising new therapeutic target to prevent or treat fibrosis of both the lung airways and parenchyma.